Age-Related Alterations in Neuro-Immune Recognition of Allergens

Project Summary/Abstract
The cutaneous sensory nervous system plays an essential role in the recognition of allergens and activation of
the allergic immune response. Protease allergens directly activate pruriceptive, or itch-inducing, sensory
neurons, leading to the sensation of itch and the local release of Substance P, which then activates and
promotes the migration of allergic-skewing dendritic cells into the draining lymph node. Our laboratory is
focused on understanding these neuro-immune interactions, specifically in identifying how pruriceptive sensory
neurons detect allergens, what subsets of pruriceptive neurons are involved in this detection, and how sensory
neuron-dendritic cell interactions are maintained in the skin. In order to better understand the neuro-immune
mechanisms controlling the initiation of the allergic immune response, we propose to study how aging leads to
defects in these mechanisms. Despite our continued exposure to new and novel allergens, the development of
new allergic sensitizations is inversely correlated with age. At the same time, the itch response in the elderly is
dysfunctional, with chronic pressure-induced itch being one of the most frequent symptoms in individuals over
65 years of age. If allergen-induced activation of pruriceptive neurons is directly upstream of allergic
sensitization, what explains the low incidence of novel allergic sensitization in the very population with the
highest prevalence of itch? Our central hypothesis is that aging leads to altered neuro-immune interactions
within the dorsal root ganglia (the anatomical location of sensory neuron cell bodies) and the skin, resulting in
dysfunctional itch responses and defective neuronal responses to allergens. Building upon our laboratory’s
expertise in innate immunology, allergy and neuro-immunology, and taking the novel approach of comparing
allergen sensitive young adult mice with allergen insensitive aged mice, we will use the tools of single cell and
single nuclear transcriptomics, cellular immunology, and neurobiology to gain a fundamental understanding of
the neuro-immune interactions required to initiate and maintain allergic immunity. We will test our central
hypothesis in two specific aims: (1) identify the age-related changes that alter the sensory neuronal response
to allergens, and (2) determine the role of age-related changes in sensory neuron function in the initiation of
allergic immune responses. Aim 1 will examine how immune cell infiltration into aged dorsal root ganglia alters
sensory neuronal populations and the sensitivity of those neurons to allergen-induced activation in both mice
and humans. Aim 2 will focus on the skin, the site of allergen exposure, and address how aging alters the
interactions between pruriceptive neurons and dendritic cells, and how age-induced alterations then impact the
initiation of the allergic immune response. By studying the physiologic processes that control itch and allergic
immune initiation, these studies will lay the groundwork for the development of therapeutic strategies to treat
and prevent allergic diseases.

Public health relevance
Project Narrative Allergic diseases afflict 40% of the United States population, but the development of new allergic sensitizations is inversely correlated with age. A research program will be undertaken to study how age-related changes in neuro-immune interactions in dorsal root ganglia and the skin lead to alterations in sensory neuron detection of allergens and initiation of allergic immune responses in both mice and men. These studies will provide fundamental basic immunological insights into how allergic disease is initiated and will lay the foundation to develop novel therapeutic strategies to prevent and treat allergic diseases.